Hypertension and inflammation: novel insights from human angiotensin type 1 receptor variants

Angiotensin II (Ang II) contributes to the pathophysiological consequences of vascular and renal
systems and angiotensin receptor type 1 (AT1R) mediates these effects. AT1R-signaling
promotes renal sodium retention, vascular remodeling, hypertension, and end organ damage.
Genetic variations that increase AT1R can cause pathological outcomes associated with renin
angiotensin system (RAS) over-activity. However, genetically variable, transcriptional regulation
of the human AT1R gene is poorly understood. Physiological variables like age and diet alter the
transcriptional milieu of cells and result in feedback activation of genes. In this regard, the human
AT1R gene has a haplotype block of four SNPs: T/A at -810, T/G at -713, A/C at -214, and A/G
at -153 in its promoter. Variants -810T, -713T, -214A, and -153A always occur together
(haplotype-I) and variants -810A, -713G, -214C, and -153G always occur together (haplotype-II).
We have found that haplotype-I is associated with hypertension in Caucasians, and have
generated transgenic mice with haplotypes-I and II of the hAT1R gene to study its transcriptional
regulation. TG mice with haplotype-I have higher expression of hAT1R with increased blood
pressure; suppression of antioxidant defenses (HO1, SOD1) and antiaging molecules (ATRAP,
Klotho, Sirt3); and, increased expression of inflammatory (IL-6, TNF, CRP, IL-1β) and oxidative
markers (NOX1). On the other hand, diet-induced obesity and aging are also accompanied by
systemic inflammation and redox imbalance that, in turn, alter the cellular transcriptional milieu.
Our preliminary studies show that higher binding affinity of transcription factors like USF2, GR
and STAT3 increase hAT1R expression in TG-mice with haplotype-I, as compared to haplotype-
II. Since AT1R up-regulation can worsen the pathological outcomes of age and diet,
understanding its gene- regulation has high translational value with significant clinical impact.
Thus, in this application we will analyze how diet and age affect the cellular gene regulatory
networks and alters hAT1R expression in our transgenic lines. To eliminate the confounding
effects of the endogenous mAT1R gene, mA1TR-/--hAT1R-TG mice will be used. Thus,
understanding the role of different physiological variables like age or diet on AT1R gene regulation
is crucial to identify patients at increased risk of feedback AT1R overexpression. This can function
as an “early warning” towards timely and directed therapeutic intervention in patients with
haplotype-I of the AT1R gene.

Public health relevance
Hypertension and inflammation are serious risk factors for heart failure, vascular disease, stroke, and renal failure. Angiotensin receptor plays an important role in renal and cardiovascular disease. Successful completion of these studies will better define the role of different physiological variables like age or diet on AT1R regulation, and its implication in identifying patients at increased risk of AT1R overexpression.